Using Momentary Measures to Understand Physical Activity Adoption and Maintenance among Pacific Islanders in the United States

PROJECT SUMMARY/ABSTRACT
Pacific Islanders represent one of the fastest growing racial/ethnic groups in the United States.
Pacific Islanders suffer from disparities in a variety of health problems such as obesity,
cardiovascular diseases, diabetes, and cancer at several sites. Although physical activity is an
effective way to reduce the risks of these health problems, Pacific Islander adults are generally
less physically activity than non-Hispanic whites. The search for effective policies and
interventions to promote PA among Pacific Islanders is severely hampered by the paucity of
research on the mechanisms underlying PA behavioral change in this population. This
longitudinal study will examine the influence of contextual and environmental factors and acute
momentary precipitants on PA adoption and maintenance among 150 sedentary Pacific Islander
adults. This study is guided by an overarching conceptual framework derived from models of the
social/environmental determinants of health, social cognitive theories of behavioral change, and
prior empirical findings. Participants will be assessed using real-time, field-based, state of the
art methodologies consisting of MotionSense, ecological momentary assessment, and GPS.
MotionSense track behavioral and physiologic data in real-time and can objectively detect PA
behaviors and negative affect/stress of participants. GPS permits real-time mapping of an
individual’s space-time trajectories and relevant environmental exposures/characteristics (e.g.,
proximity to PA facilities; neighborhood safety) using geographic information system data.
Principal outcomes of interest are PA adoption and PA maintenance. This research would be
the first to systematically study PA behaviors of Pacific Islander adults and the first to combine
objective and dynamic indices of PA, negative affect/stress, and key environmental influences in
PA behavior studies. The comprehensive, multi-method approach is a major advance for the
field as it eliminates problems related to an exclusive reliance on self-reports and static
residential locations for key outcomes and predictors. In addition, this is one of the first studies
to include the framework of dynamic prediction models, a novel statistical approach, to fully
examine the huge amount of data yielded by real time assessment approaches. The results will
provide critical evidence to guide policies and interventions targeted at reducing PA-related
health disparities experienced by Pacific Islanders and potentially other racial/ethnic minorities.

Public health relevance
NARRATIVE/PUBLIC HEALTH RELEVANCE This project will examine the influences of neighborhood built and social environments, acute individual and contextual precipitants, as well as demographics and social history, biobehavioral and psychosocial predispositions on physical activity (PA) adoption and maintenance among sedentary Pacific Islander adults in Utah. It will use emerging mobile health technologies to measure PA and its key correlates in real time in the real world. The study will fill key gaps in the literature on important correlates and mechanisms underlying PA behavioral change for this fast-growing, high health risk, yet severely understudied population group, and will provide critical information on how to improve their PA level and reduce obesity and obesity-related health problems. The methodology and findings derived from this study will also provide a new perspective in understanding PA behavior of other racial/ethnic groups with high obesity and low PA levels.